Transgenic Mouse

The availability of the Transgenic Mouse Shared Resource enables our CCSG Research Base Investigators to conduct versatile, cutting-edge research with a battery of sophisticated genetic techniques for manipulation of the mouse genome to create models for studies of cancer for incisive in vivo mechanistic investigations of the fundamental processes involved in the etiology of tumor development. Transgenic mice carrying new or novel genes are created by microinjection of DNA into the pronuclei of fertilized eggs and knock-out mice lacking specific genes of interest are created by homologous recombination in embryonic stem cells followed by injection into blastocysts to create chimeric mice for breeding to homozygosity. The high degree of conservation of most sequences in genomes of humans and mice makes using mouse genetic manipulation technology to create models of human cancer pathogenesis extremely useful. These approaches are remarkably powerful in cancer research particularly in the analysis of oncogenes, metastasis, cell-cycle control, tumor suppressor genes, and in the crafting of cancer model systems for developing new treatment regimens, and methods for drug testing and tumor imaging. The mission of this Shared Resource is to provide the highly technical aspects of manipulation of genes in embryos and mouse embryonic stem cells as a service to our Center members, allowing them to create the genetically manipulated mouse models they need. This is an outstanding example of specialized techniques, highly trained dedicated personnel, and expensive equipment can be accessed by researchers who could not reasonably expect to develop or obtain them on an individual basis. The UCSD CCSG Shared Resource provides cutting-edge, rapidly evolving services that adapt and drive the field of mouse genetics and continue to be very responsive to the vast creativity of the CCSG membership, fulfilling their needs for the most cutting-edge embryology and molecular genetics in the mouse.

Public health relevance
The availability of the Transgenic Mouse shared Resource enables our researchers to conduct versatile cutting-edge research with a battery of sophisticated genetic techniques to address the fundamental questions in cancer research. Mouse models are ideal for determining the genetic basis of oncogenesis and studying the fundamental processes involved in the etiology of tumor development and metastasis.